Defining mechanisms driving salivary gland regeneration

Project Summary/Abstract
The development of stem cell-based therapies for curing disease and restoring organ function has led to a critical
need to identify endogenous stem cells and their regulators in craniofacial tissues. We have made significant
inroads into deciphering stem cell identity and regulation in the salivary gland, a craniofacial organ system
profoundly affected by chronic diseases (e.g., aging, autoimmunity, cancer) for which there are few symptomatic
treatments and no long-term restorative therapies. However, despite progress in the field, we are still very much
in the early stages of understanding the mechanisms driving organ repair and regeneration. Thus, based our
previous studies revealing the identity and function of salivary progenitors and novel roles of cholinergic nerves
in morphogenic and renewal programs, we seek to elucidate the mechanisms driving salivary gland regeneration
by exploring 4 significant questions: (1) How do salivary stem cells enable organ renewal? (2) How do nerves
control organ homeostasis and regeneration? (3) How does aging impact salivary stem cells? And finally, (4)
How is salivary gland architecture created? We will answer these questions using a combination of
developmental and regenerative approaches in mice and human tissue together with a bevy of molecular,
biochemical, imaging and cell biological assays. Outcomes here will uncover novel cellular and molecular
mechanisms required for the development of stem cell based therapeutics for reversing damage in these and
other organ systems.

Public health relevance
Project Narrative My laboratory is pursuing fundamental questions about salivary gland development, maintenance and repair: (1) How do salivary stem cells enable organ renewal? (2) How do nerves control organ homeostasis and regeneration? (3) How does aging impact salivary stem cells? And finally, (4) How is salivary gland architecture created? We explore these questions with the ultimate goal of generating restorative therapies for restoring salivary function and improving quality of life.